Mapping transient interactions with and on genomic DNA

PROJECT SUMMARY
Collisions between the DNA replication and transcription machineries – known as Transcription-replication
conflicts (TRCs) appear to occur in all eukaryotes. Although these conflicts have been extensively investigated
as a source of genome instability, we currently lack tools to determine how frequently these conflicts occur,
where they are located in the genome, and whether the two complexes meet in a head-on or a co-oriented
disposition.
In addition to unwinding DNA to generate two single strands to serve as the template for replication, DNA
helicases play diverse roles in DNA replication and repair. Mutations in genes encoding helicases are implicated
in a number of human diseases including but not limited to cancer. A major limiting factor in our understanding
of helicase function in cells is an inability to precisely determine the sites at which they are active.
The proposed work encompasses two ongoing projects:
Existing methods to map protein-DNA interactions do not distinguish sites at which a helicase is close to DNA
from those at which it is actively unwinding. The first project takes advantage of a novel strategy to map helicase
activity on genomic DNA via fusion to a single-strand-specific cytidine deaminase. Using this strategy, we will
define the targets of Pif1-family helicases at high resolution, investigate the degree to which partially redundant
helicases can compensate for one another, and determine which sites each helicase targets during each phase
of the cell cycle. This work will also establish pipelines that will allow future investigation of other helicases and
single-stranded DNA binding proteins in unicellular and multicellular eukaryotes.
The second project will advantage of an optimized split-enzyme proximity biotinylation system to map genomic
loci at which replication and transcription complexes physically interact. Among other experiments, we will test
a long-standing model wherein replication forks can bypass transcribing RNA polymerases without evicting them,
allowing for the resumption of transcription without loss of the nascent RNA transcript.
The core DNA replication and transcription machineries, as well as most helicases, are highly conserved
throughout eukaryotes. Both projects will be carried out in the budding yeast Saccharomyces cerevisiae: the
small genome, rapid replication, and genetic manipulability of S. cerevisiae make this an ideal model in which to
study the intersection of fundamental biological processes. Therefore, the results of this work will provide
molecular insights into genome instability in humans; these results will be directly applicable to our understanding
of the etiology and progression of cancer, as well as diseases associated with impaired helicase function.

Public health relevance
PROJECT NARRATIVE Transcription occurs on genomic DNA throughout the cell cycle, including during the S-phase when DNA is replicated: collisions between replication and transcription complexes have the potential to lead to DNA damage and genome instability. One project will map and characterize direct physical interactions between transcribing RNA polymerases and components of the replication machinery, allowing us to understand where these conflicts occur and how their impact on genome integrity is mitigated. A second, related project takes advantage of a new method we have recently developed to identify where DNA helicases – proteins that unwind DNA – are acting in cells: we will apply this method to study how partially redundant helicases compensate for one another when one is absent, and how their activities are regulated through the cell cycle.